Racial/Ethnic Disparities in Medicare Advantage vs. Traditional Medicare: Evidence to Improve Equity in Medicare

PROJECT SUMMARY / ABSTRACT
The Medicare Advantage (MA) program has experienced substantial growth over the last decade, particularly
among racial/ethnic minorities. MA offers an alternative to traditional Medicare (TM) coverage by allowing
Medicare beneficiaries to receive integrated medical and prescription drug coverage from private insurers.
Although MA serves a growing population of Black and Hispanic beneficiaries, it remains unclear whether MA
mitigates or exacerbates racial/ethnic disparities in care, as well as whether certain MA plans provide higher
quality and more equitable care for Black and Hispanic enrollees than other MA plans. Rigorous evidence is
needed to identify opportunities to reduce health care disparities in the Medicare program and design
incentives for MA plans to improve care for Black and Hispanic enrollees. Thus, the overarching objectives of
this study are to investigate whether enrollment in MA mitigates or exacerbates racial/ethnic disparities (i.e.,
between Black vs. white and Hispanic vs. white beneficiaries) in access, quality, and utilization of care relative
to TM; to identify high-quality and high-equity MA plans; and to develop and validate measures of patient
experiences with trust, discrimination, and equitable care that could be incorporated into future assessments of
MA plan performance. We draw on rich sources of national data, including the Medicare Current Beneficiary
Survey and encounter claims submitted by Medicare Advantage plans, and will also conduct a national survey
of Medicare beneficiaries to assess experiences with trust, discrimination, and equity in care to evaluate
disparities along different dimensions of care (access, quality, and patient experiences). We will go beyond
existing surveys of the Medicare population by explicitly surveying beneficiaries about their experiences with
equity, trust, and discrimination in care, and will provide evidence to guide how these items could be
incorporated into future surveys of patient experiences and assessments of MA plan performance (e.g., plan
star ratings). Thus, this project will illuminate how key features of the MA program overall, and attributes of
particular MA plans, affect care for racial/ethnic minorities. It will also provide new evidence to inform how
policymakers could take equity into account when evaluating the quality of MA plans, including assessing
patient experiences with equitable vs. inequitable care. This work addresses NIA’s strategic priorities for 2020-
25 to identify health system factors underlying disparities and policy opportunities to reduce health care
disparities among older adults. To enhance the impact of our work, we will disseminate findings through
scientific publications and to a national network of policy stakeholders, including a Policy Advisory Committee
comprised of experts in Medicare policy, the MA program, and disparities.

Public health relevance
PROJECT NARRATIVE The Medicare Advantage (MA) program serves a growing number of Black and Hispanic beneficiaries, but evidence about the quality and equity of care in MA compared to the traditional Medicare (TM) program is limited. This study will use national MA encounter (i.e., utilization) and survey data, including a new national survey of Medicare beneficiaries, to examine racial/ethnic disparities in care between the MA and TM programs and among MA plans, and to assess patients’ experiences of equity and trust in Medicare plans and providers. This work will illuminate opportunities for the MA program to improve care for racial/ethnic minorities and for policymakers to explicitly incorporate equity into assessments of MA plan performance, with the objective of reducing racial/ethnic disparities in care among Medicare beneficiaries.